Sex disparities in hypoxic sympatholysis and impact of obesity

PROJECT SUMMARY
Parent grant “Sex disparities in hypoxic sympatholysis and impact of obesity” #R01HL153523
Strong evidence implicates the sympathetic nervous system as a key regulator of peripheral blood
flow and blood pressure during hypoxia. Herein, we present striking sex-differences in the
neurovascular response to hypoxia that challenge current dogma. Our results are corroborated
by epidemiological data showing sex disparities in the prevalence of hypertension and
progression of cardiovascular disease in conditions of hypoxemia (i.e., sleep apnea). However,
contributing mechanisms (including α- and β-adrenergic receptor activity, sensitivity, and
expression) remains a critically unanswered question. The present study will fill this gap in
knowledge while also determining whether these mechanisms are impaired with obesity. Nearly
70% of the US population is overweight or obese, with the prevalence of obesity even greater in
patients with sleep apnea. Obese adults exhibit greater sympathetic nervous system activity and
higher risk for hypertension than normal weight adults. Emerging data indicate the impact of
obesity on cardiovascular health is disproportionate in women versus men and it is reasonable to
propose this is exaggerated with the addition of hypoxic stress. The purpose of this application
is to examine key mechanisms contributing to sex-differences in hypoxic vasodilation and the
impact of obesity, with particular emphasis on the sympathetic nervous system. Our central
hypothesis is that young premenopausal, normal weight women are protected from the
sympathetic vasoconstrictor effects of hypoxia, and the “beneficial” effect of female sex is lost
with obesity. Based on strong preliminary data, we anticipate α-adrenergic mediated
vasoconstriction is exaggerated and β-adrenergic and downstream nitric oxide-mediated
vasodilation are attenuated in obese women. We will test our central hypothesis via the following
specific aims: The first aim of this project will determine sex differences in α-adrenergic receptor
mediated vasoconstriction during acute hypoxia as well as the impact of obesity. We propose a
comprehensive approach of intra-arterial drug infusions of α-adrenergic agonists and antagonists,
combined with direct measures of muscle sympathetic nerve activity in normal weight men,
normal weight women, and obese women. The second aim of this project will determine the
direct and modulatory effect of the β-adrenergic receptors on hypoxic vasodilation as well as
impact of obesity. We will collect human arterial endothelial cells and measure the peripheral
vascular response to hypoxia prior to and following intra-arterial infusion of select β-adrenergic
agonists and antagonists. This experimental approach will allow us to strategically assess β-
adrenergic receptor activity, sensitivity, and expression in the context of hypoxia as well as down-
stream mechanisms. Our proposed findings will advance the fundamental, mechanistic
understanding of hypoxic vascular control in women, and results will ultimately guide the
development of new strategies to treat and prevent vascular pathophysiology.

Public health relevance
PROJECT NARRATIVE Parent grant “Sex disparities in hypoxic sympatholysis and impact of obesity” #R01HL153523 Patients with sleep apnea are at increased risk of developing cardiovascular disease – with women at potentially greater risk than men. Contributing mechanisms are not well understood, but may be related to how women respond to low oxygen and, given over 70% of patients with sleep apnea are obese, the impact of obesity. The proposed project seeks to increase our understanding of mechanisms that may contribute to sex differences in the cardiovascular response to low oxygen with the hope that this knowledge will improve the efficacy of current therapies and support the discovery of novel therapeutics.